Molecular Cloaking Devices for Manipulation of Cysteine Post-Translational Modifications

Project Summary
Post-translational modifications (PTMs) of proteins are involved in virtually all cellular signaling pathways.
Pharmacological intervention in these events is an important strategy for drug development. In this project, we
propose to establish a novel platform for the discovery of covalent inhibitors of cysteine post-translational
modifications, in particular, the prenylation of the C-termini of H-Ras and K-Ras. These events are critical for
oncogenic mutants of these proteins to drive cell uncontrolled growth and division. In contrast to typical
strategies for blocking PTMs, we will screen for non-peptidic macrocycles that bind covalently to the modified
epitope on the substrate protein (H-Ras or K-Ras), rather than compounds that target the modifying enzyme. In
this way, we believe it will be possible to manipulate single PTMs with unprecedented selectivity.

Public health relevance
Project Narrative This project will attempt to develop a platform for the facile isolation of covalent inhibitors of post-translational modifications (PTMs) of cysteine thiols, specifically the prenylation of the C-termini of H-Ras and K-Ras, events critical for their oncogenic activity. Our approach is highly novel. Rather than attempting to inhibit the enzymes that mediate these PTMs, we will screen DNA-encoded libraries for non-peptidic macrocycles able to engage the modified epitope itself, resulting in it being “cloaked” and thus unrecognizable by the modifying enzymes as a substrate.